Project 2: Systemic Understanding of Cellular Mechanisms of Metabolic Adaptations in Cancer

ABSTRACT
Cancers are characterized by alterations to cellular metabolism that promote tumorigenesis, however our understanding of how these metabolic changes are enacted and how they mechanistically support cancer cell function remains lacking. While some metabolic changes reproducibly occur as a direct result of oncogenic mutations, other metabolic alterations occur over time through adaptive metabolic protein expression changes that allow cells to surmount metabolic deficiencies during cancer progression. Notably, this latter group is predicted to be enriched for functionally important metabolic changes, suggesting that their identification would have particularly relevance for cancer research. However, detailed understanding of which metabolic alterations are the result of adaptations is hampered by the lack of models for directly studying reproducible
metabolic adaptations in cancer.
Here, we propose to address this knowledge gap by investigating the mechanisms of metabolic adaptation system that we have recently established, where loss of function mutations in the tumor suppressor succinate dehydrogenase (SDH) selects for cells with concordant expression of components of mitochondrial electron transport chain complex I, which ultimately supports cell metabolism and cell proliferation. Using this system, we will investigate the metabolic drivers of complex I adaptations in SDH deficient cells (Aim 1) and use polyomics measurements of gene expression processes, such a epigenetics, transcription, and proteostasis, to identify the cellular processes that enact adaptive changes to complex I expression (Aim 2). We will also take a systematic approach using state-of-theart statistical methods to leverage publicly available patient tumor datasets containing polyomic measurements and patient metadata in order to identify adaptive changes to metabolic protein expression during cancer progression (Aim 3). This multidisciplinary Full Project also addresses the Partnership’s Guiding Principles for research teams and for research dissemination to catchment area communities, helping to educate and provide opportunities for next generation of researchers.

Public health relevance
This Full Project combines the expertise of cancer metabolism research and biostatistics to deepen our understanding of the mechanisms of metabolic adaptation. The multidisciplinary collaboration enhances cancer research education opportunities by transferring knowledge of metabolism and statistics across institutions and student training levels. The team members will benefit from cancer/biostatistics and career development workshops supported by the Research Education About Cancer and Health (REACH) Core. Drs. Jeon and Sullivan will also interact with the Resource for AcademIc SuccEss (RAISE) Core by participating in mentoring and career planning activities for early-stage investigators. The project members and students will disseminate research findings and their experiences to communities in our catchment areas in collaboration with the Outreach Core. The Full Project team will foster positive scientific environments through joint meetings between Jeon and Sullivan’s groups of researchers, promoting all students to increase their cancer research experience and enhancing opportunities to reinforce their science identity. This Full Project will advance the Partnership, strengthening cancer research capabilities through a new, synergistic collaboration between NMSU and Fred Hutch researchers. This commitment to training and mentoring scientists will also support community engagement and health outcomes.